Clinical-Translational Studies in Skin, Lung, and Vascular Complications in Systemic Sclerosis

The Administrative Core of the Core Center for Clinical Research (CCCR) for Improving Health in Rheumatic Diseases (ImHeaRD) at the Medical University of South Carolina provides leadership and management for the center and a pilot projects program that is funded entirely with institutional commitments. The mission of this CCCR is to advance knowledge and improve health outcomes for populations that bear a disproportionate burden of systemic lupus erythematosus, systemic sclerosis, vasculitis, and other debilitating rheumatic diseases, as identiﬁed by objective epidemiologic and socioeconomic indicators. All CCCR services, resources, and pilot funding are offered on a nondiscriminatory, merit-based basis and in full compliance with applicable Federal civil- rights laws, executive orders, and NIH policies. The overarching goals of the Administrative Core are to: (a) ensure the quality, validity, accessibility and applicability of the tools, services, samples, data and other output of the CCCR cores, (b) foster interactions among basic, translational and clinical scientists at MUSC and beyond to focus effectively on prevention, diagnosis and treatment of rheumatic diseases, (c) facilitate appropriate dissemination of research results and resources, and (d) establish/continue collaborations with other CCCRs/CORTs to share best practices, methodology and unique skills. To achieve these goals, we will pursue the following speciﬁc aims: 1. Provide leadership for the CCCR; 2. Coordinate and manage CCCR organizational, operational and ﬁnancial functions and evaluative activities; 3. Leverage institutional infrastructure resources; 4.
Conduct a multi-year Evaluation Plan; 5. Strengthen and expand robust communication, dissemination and outreach activities, fostering mutually productive interactions among health professionals, scientists and local communities; and 6. Provide a competitive, open, competitive, peer-reviewed Pilot Projects Program. This core will be directed by Jim Oates, MD, with assistance from two Associate Directors, Gary Gilkeson, MD, and Diane Kamen, MD, an Executive Committee that includes core leaders and Research Community representatives, an Internal Advisory Committee that includes institutional stakeholders and patient advocates, and an External Advisory Committee that includes experts in the ﬁeld with experience leading other NIAMS centers. The Administrative Core staff provides administrative support for the center, administering and monitoring the ﬁnances, coordinating meetings and action items, and interfacing with NIAMS staff and institutional personnel. The Administrative Core also supports educational and dissemination activities to enhance the visibility and impact of the center within MUSC and the local community and provide a forum for communicating and exchanging research ideas. The Administrative Core nurtures a vibrant, interactive program of clinical and translational research to advance our knowledge and resources for improving the prevention, diagnosis, treatment and health outcomes for rheumatic diseases.*

Public health relevance
The Administrative Core provides leadership, coordination, and oversight for a research center at the Medical University of South Carolina that accelerates prevention, diagnosis, and treatment of systemic lupus erythematosus, systemic sclerosis, vasculitis, and related rheumatic diseases. Through fair, merit-based access to shared resources, rigorous evaluation, and a competitive pilot program, the Core helps researchers turn discoveries into practical advances in patient care. By prioritizing efforts where the public health burden is highest—based on objective epidemiologic and socioeconomic indicators—this work aims to reduce disability, hospitalizations, and premature deaths from rheumatic diseases.